Population-Based Evaluation of Artificial Intelligence for Mammography Priorto Widespread Clinical Translation

PROJECT SUMMARY

Multiple artificial intelligence (AI) technologies are now commercially available for automated interpretation of screening mammography. These AI technologies hold promise for improving screening performance and outcomes for the 40 million U.S. women who undergo routine breast cancer screening each year. Federal regulatory approval of new AI technologies requires only a demonstration of non-inferior accuracy to existing computer-aided detection systems in small, retrospective reader studies, but their widespread clinical translation is contingent upon more robust population-based evaluation. Specifically, the impact of these AI technologies on actual patient outcomes needs to be assessed, including whether or not they lead to improved detection of clinically meaningful cancers in the general screening population. Robust external validation of AI algorithms for mammography screening has thus far been limited by use of single institution datasets not representative of the entire target population, use of AI algorithms that are not publicly available, comparison to radiologist performance in enriched case sets, limited follow-up time for cancer diagnoses influencing ground truth labels, and evaluation on 2D digital mammography rather than 3D digital breast tomosynthesis (DBT) exams. Our study objective is to conduct a comparative evaluation of four commercially available AI technologies for automated DBT screening interpretation that overcomes all of these limitations and then estimate the long-term benefits, harms, and costs of AI-driven DBT screening at the U.S. population level. Specifically, we will 1) use a centralized honest broker, model-to-data paradigm infrastructure to perform an independent, external validation of four leading commercial AI technologies for DBT screening using prospectively collected data obtained from seven diverse U.S. regional breast imaging registries; 2) stratify AI vs. radiologist performance on detailed woman-, exam-, radiologist-, and tumor-level characteristics to inform targeted algorithm training and refinement efforts to ensure generalizability of the AI algorithms; 3) explore targeted approaches for improving clinical workflow efficiency by using AI to safely triage exams highly likely to be negative; and 4) use a validated breast cancer microsimulation model to determine population-level, long-term health benefits, harms, and costs associated with four commercially available AI technologies for DBT screening both as a standalone screening tool and as a second independent reader to radiologist interpretation. Our proposed study will represent the most objective and rigorous evaluation of deep learning algorithms for DBT screening interpretation in the U.S. to date. Our results will provide urgently needed evidence to inform key stakeholders including women, physicians, payers, industry partners, and policymakers regarding how to maximize the value of AI technologies for DBT screening prior to their widespread clinical translation.

Public health relevance
Project Narrative While nearly 40 million women in the United States undergo mammography screening each year, 1 in 8 breast cancers are still missed due to the limitations of human radiologist interpretation even with the use of newer tests like 3D mammography. Recently, multiple promising artificial intelligence technologies for automated mammography interpretation have become commercially available but are unlikely to be widely adopted in clinical practice until they are shown to improve screening outcomes over radiologist interpretation alone. We will evaluate the performance of four leading artificial intelligence technologies for automated 3D mammography interpretation on a diverse national screening cohort and then leverage an established breast cancer simulation model to estimate the long-term benefits, harms, and costs associated with adopting AI tools for 3D mammography interpretation for the U.S. screening population to inform key stakeholders prior to their widespread clinical translation.